Cellular and molecular regulators of melanocyte regeneration

PROJECT SUMMARY:
The proposed studies seek to isolate and characterize melanocyte stem cells (McSCs) as well as identify the
signals and pathways that govern McSC-mediated melanocyte regeneration. McSC gene expression will be
characterized using single-cell RNA sequencing (scRNAseq). In zebrafish we will perform longitudinal
sampling of McSCs during regeneration to uncover pathways, both cell intrinsic and extrinsic, involved in
determining McSC fates. scRNAseq of samples from vitiligo patients will also be performed to identify human
McSCs and assess signaling active in these cells. Preliminary studies have identified novel candidate
pathways in McSC biology, including NGFR signaling. This pathway is intriguing because NGFR is a marker of
melanoma initiating cells and was recently found as a defining feature of dedifferentiated melanoma cells that
are resistant to both immune checkpoint inhibitor and BRAF inhibitor therapies. Our data lead to the hypothesis
that NGFR signaling supports the McSCs cell state and this activity is co-opted by melanoma cells in tumor
maintenance and drug resistance. Functional studies in zebrafish will be used to interrogate NGFR and other
candidate pathways. Pathways suspected to be important in McSC fate execution, KIT and macrophage-
mediated, will be also probed using similar methodologies. Combinatorial pathway manipulations will be
performed to assess how these different pathways depend on each other to regulate regeneration. scRNAseq
will inform the targeted pathway studies, serve as a resource to identify new McSC-regulatory signals, and
provide insight into the conservation of McSC signaling across species. This combination of experiments will
provide a detailed understanding of melanocyte stem cells and the controls that guide them during the
regeneration process.
The specific aims of this proposal are:
Aim 1: Define transcriptional changes and cellular trajectories of McSCs and other cells during
regeneration
Hypothesis: Regeneration is characterized by broad transcriptional changes that reflect cell state changes and
engagement of regulators in response to tissue injury.
Subaim 1A: Map the transcriptional and cellular changes that occur during melanocyte regeneration in
zebrafish
Subaim 1B: Define human McSCs and their descendants using scRNAseq of vitiligo and normal skin
Aim 2: Determine and functionally analyze signaling pathways involved in McSC maintenance and
melanocyte regeneration
Hypothesis: A network of cellular signaling systems coordinately regulates McSC maintenance, activation and
fate execution.
Subaim 2A: Identify signaling pathways whose activities change in McSCs and their descendants
during regeneration
Subaim 2B: Functionally analyze pathways involved in McSC maintenance and activation
Subaim 2C: Investigate the roles of macrophages and other intermediary cell types in regeneration

Public health relevance
PROJECT NARRATIVE: Melanocyte regeneration is important for the homeostasis and repair of pigmented skin. This proposal seeks to identify and characterize genetic and cellular factors that guide melanocyte regeneration, primarily utilizing the advantages available in the zebrafish system. The knowledge gained from these studies aims to positively impact treatment of individuals with pigmentary disorders, including the 0.2-1.8% of the world’s population with vitiligo.